In-silico screen and in-vivo evaluation of FDA-approved drugs to treat noise-induced hearing loss

Acquired hearing loss is a major public health concern, affecting quality of life and leading to social isolation,
depression, and cognitive decline. Roughly one-third of all acquired hearing loss cases are attributed to noise-
induced hearing loss, a prevalent occupational injury. Current interventions, such as hearing aids and cochlear
implants, provide limited relief and are imperfect solutions.
The mammalian inner ear sensory hair cells, spiral ganglion neurons, and cells of the stria vascularis are
particularly vulnerable to irreversible damage and do not regenerate upon injury, making noise-induced or age-
related cellular loss permanent. They are highly metabolically active and rich in mitochondria. Hence,
mitochondrial dysfunction is a leading cause of several forms of deafness. As in many other cell types, cochlear
mitochondria are responsible for vital functions, including energy production, cell signaling, calcium (Ca2+)
buffering, and apoptosis. These functions are dependent on mitochondrial Ca2+ entering through the multi-protein
Mitochondrial Calcium Uniporter (MCU) complex, whose human atomic structure is solved and known.
MCU contributes to rapid mitoCa2+ buffering, ensuring cytosolic Ca2+ homeostasis. Previous studies report that
acoustic overstimulation causes elevated cytoplasmic Ca2+ levels in hair cells, leading to mitochondrial Ca2+
overloading. Inhibition of MCU activity using genetic manipulation to knock-out MCU components or systemic
application of a MCU inhibitor reduced noise-induced auditory threshold shifts and prevented the loss of hair
cells and synaptic ribbons. We hypothesize that MCU can be targeted pharmacologically to prevent noise-
induced hearing loss. By modulating MCU activity through repurposing FDA-approved drugs, we aim to expedite
the development of novel treatments to mitigate cochlear damage and maintain hearing function following noise
insult. Our comprehensive approach involves in silico screening to identify MCU modulators, with subsequent in
vitro, ex vivo, and in vivo evaluations of candidate compounds for safety and efficacy to repurpose FDA-approved
compounds as otoprotective drugs. The top candidate drug will be delivered to mice trans-tympanically
immediately after noise trauma and tested for their ability to prevent noise-induced hearing loss. The cochlear
structure and function will be evaluated at various time points during recovery with well-established techniques.
In summary, our study aims to identify FDA-approved drugs capable of reversibly blocking mitochondrial Ca2+
uptake to prevent noise-induced damage that mitochondria-rich cochlear cells undergo following noise insult.
Reversible modulators will ensure the effect is temporary and relevant only during the critical recovery period
immediately following noise trauma. Unlike typical slow and expensive de novo drug discoveries, repurposing
FDA-approved drugs offers a cost- and time-efficient alternative for discovering novel therapies.

Public health relevance
Narrative Our goal is to address the prevalent challenge of acquired hearing loss in our aging population, often resulting from exposure to noisy workplace settings and other environmental noise sources. We explore the potential of modulating the Mitochondrial Calcium Uniporter complex by repurposing FDA-approved drugs to reduce mitochondrial calcium overload in cochlear cells, thereby preserving hearing function. Through a multifaceted approach involving in silico, in vitro, ex vivo, and in vivo methodologies, we will identify FDA-approved compounds capable of mitigating noise-induced hearing loss in a cost-efficient manner. 1